CLINICAL, BEHAVIORAL &NEUROCHEMICAL STUDY OF FRONTAL TEMPORAL DEMENTIA

To better understand the relationship between frontal temporal dementia and Alzheimer's Disease. To compare FTD and AD subjects using new clinical scales, laboratory tests and special fluid analysis.